Zeiss LSM900 laser scanning confocal microscope for the University of North Carolina at Chapel Hill

Project Summary/Abstract
The University of North Carolina at Chapel Hill (UNC-CH) is requesting a Zeiss LSM900 laser scanning confocal
microscope. This instrument will replace an obsolete Zeiss LSM710 microscope installed in 2009, which is no
longer supported by the manufacturer, and is at risk of failing. If that system were to fail, its current usage levels
could not be fully accommodated on equivalent instrumentation at UNC-CH, jeopardizing multiple NIH-funded
research projects. The Zeiss LSM900 is a modern, reliable instrument that has the necessary capabilities to
support projects in the laboratories in this submission’s User Group. This Group consists of 21 laboratories,
arrayed in 11 Departments across two Schools (Medicine, Arts and Sciences), with over $30,300,000 in active
NIH funding. All these laboratories are associated with the Lineberger Comprehensive Cancer Center, and
conduct research whose discoveries can benefit public health.
This laser scanning confocal microscope will allow researchers to easily obtain images of biological specimens
with high contrast, by removing out-of-focus light using a confocal pinhole. The Zeiss LSM900 model is the best
option for the User Group given its demonstrated capabilities, reliability, cost-effectiveness, and the extensive
experience of the User Group and core facility staff with its software and hardware, all of which are documented
in detail in this submission. The microscope will be outfitted with the following optional components: a motorized
stage, a transmitted light detector, and three sensitive GaAsP detectors. These components are essential to
meet the needs of the User Group.
The University is requesting $261,741 in Federal Funds, which it will supplement with $63,181 from internal
sources to extend the warranty upon purchase to the maximal amount allowable by the manufacturer (5 years).
This microscope will be placed in the Microscopy Services Laboratory, a recharge core facility with a 30+ year
history supporting the microscopy needs of the UNC-CH community. The core is strongly supported by the
University, has personnel with demonstrated expertise in the type of instrument being requested, a strong track
record training and assisting researchers, and a large, broad, and active user base of more than a hundred labs
and several hundred researchers.
We expect this instrument will rapidly become an essential component of the shared microscopy infrastructure
at UNC-CH that will catalyze major discoveries across multiple subject areas.

Public health relevance
Project Narrative To understand the cause of diseases, scientists study cells that serve as models of those diseases. This microscope will allow scientists to study what happens inside those cells, in detail. Discoveries of mechanisms of disease could be used to find treatments and cures and will benefit public health.